Assessment of Fetal Alcohol Spectrum Disorders (FASD) Using Novel Web-Based Tools - Diversity Supplement C. Estrada

Project Summary
Fetal alcohol spectrum disorders (FASD) are one of the most common developmental disabilities but are often
overlooked by clinicians. FASD is associated with alterations in facial characteristics, cognitive and behavioral
functioning, and in brain structure. The aim of the parent grant is to deploy web-based tools in efforts to improve
FASD detection accuracy. One such tool is BRAIN-online, a test of cognition and behavior that was developed
by Dr. Mattson, the PI of the parent grant. This supplement will support the trainee, Celeste Estrada, as she
acquires skills in both web-based and in-person neuropsychological assessments and contributes to the goals
of the parent award. With mentorship from the PI, Ms. Estrada will learn about experimental design,
neuropsychological assessment, and data analysis. She will conduct an independent research project that is
consistent with the aims of the parent grant. In this project, she will compare performance on BRAIN-online in
individuals who are Native English speakers to those who are multilingual English/Spanish speakers.
Participants with FASD and controls will be included. She will present the results of her study through poster
presentations (e.g., at the Research Society on Alcoholism (RSA) an/or International Neuropsychological Society
(INS) conferences) and peer-reviewed papers. She will also utilize her advanced biliteracy skills to further
investigate language spoken and FASD in additional studies if warranted by her initial project.
As part of her training plan, Celeste will complete a series of training courses corresponding to research ethics
and development, including SDSU’s Human Research Protection Program (HRPP) educational offerings.
Celeste’s ultimate goal is to gain admission into an APA-accredited doctoral program in clinical psychology. As
part of the research and career development plan proposed in this application, she will learn alongside current
doctoral students which will both broaden her experience in the lab and provide peer mentorship from students
who have recently and successfully navigated the application process for doctoral programs. The support of this
supplement will allow Ms. Estrada to complete career development and research activities as she earns her
master’s degree and pursues a research career investigating the impacts of prenatal alcohol exposure.

Public health relevance
Project Narrative The parent grant that provides the basis for this diversity supplement is directly relevant to public health concerns related to the effects of prenatal alcohol exposure on child health and development. The parent study aims to improve the screening of FASD by deploying web-based tools that aid in clinical evaluation. Two main tools will be used, the FASD-Tree and the Brief Assessment of Individual Neurobehavior – online version (BRAIN-online). Both tools use web-based technology for collecting data and provide the clinician with information about the individual’s physical, behavioral, and cognitive attributes. Data from these novel tools will be combined with traditional and advanced physical measurements collected through other CIFASD projects and will enhance clinical decision-making. The supplement will allow the candidate, Celeste Estrada, to strengthen her training and experience in alcohol research, neuropsychological assessment, and research skills which will help her attain her goal of admission to a doctoral program in clinical psychology and a research career focused on early life stressors in children with prenatal alcohol exposure.